Nanoparticle Distributed Intravenous Enzyme Replacement Therapy (NanoDIVERT)

PROJECT ABSTRACT
Enzyme replacement therapy (ERT) has been successful in ameliorating symptoms of patients with non-
neuropathic lysosomal storage disorders (LSDs), making it a viable therapeutic approach for these rare, orphan
genetic diseases. Essentially, patients receive intravenous (IV) infusions of endogenous enzymes that are either
present at low concentration, missing entirely, or misfolded, and therefore dysfunctional due to their genetic
disease. Despite its promise in the clinic, ERT cannot be used to treat 50-70% of LSDs with central nervous
system manifestation due to the blood-brain barrier (BBB) which prevents the passage of recombinant enzymes
from the blood into the brain. One of these diseases and the focus of this proposal, GM1 gangliosidosis, arises
from variants in GLB1 that leads to decreased production of lysosomal β-galactosidase (βgal). Its most common
form results in mortality between the ages of 2 and 4. Recently, our laboratory has created nanoparticle vesicles,
called polymersomes, capable of encapsulating and delivering βgal to lysosomes of GM1-affected cells, where
the delivered enzyme maintains its activity. Preliminary data in a feline model of GM1 gangliosidosis shows that
with the addition of an apolipoprotein on the surface, polymersomes transport active βgal across the BBB within
48 hours after an intravenous forelimb injection. This approach to treatment, titled nanoparticle distributed IV
ERT (NanoDIVERT), can potentially extend ERT into the central nervous system, which could impact not only
GM1 gangliosidosis but also other orphan neuropathic LSDs. To further test the applicability of the nanoparticle-
mediated approach to IV ERT, we will optimize in vivo performance. Specifically, we aim to increase delivery to
the brain and determine the most appropriate dosing for therapeutic effects. We aim to initially optimize
NanoDIVERT in a murine model of GM1 gangliosidosis, for testing in greater animal numbers, before scaling up
to large animal models. The outcome of these studies could enable the development of a clinically relevant ERT
for GM1 gangliosidosis and other neuropathic LSDs for the first time.

Public health relevance
PROJECT NARRATIVE Patients with lysosomal storage diseases suffer from degenerative symptoms that affect the entirety of their bodies. Most such patients can receive treatment through intravenous injections of needed enzymes, but patients whose brains are affected have no available treatment. GM1 gangliosidosis is one of these neurologic lysosomal storage diseases that results from a lack of production of one enzyme, beta-galactosidase. The overarching goal of this project is to develop nanoparticles to deliver this enzyme across the blood-brain barrier as a treatment for this rare and fatal disorder. Findings could be used to develop other nanoparticle-based delivery systems for a variety of brain diseases.